The role of m6A RNA methylation in C9ORF72-ALS/FTD

PROJECT SUMMARY
Amyotrophic lateral sclerosis (ALS), an adult onset motor neuron degenerative disease,
is increasingly recognized to have clinical, pathological and genetic overlaps with Frontotemporal
dementia (FTD). Dysfunction of RNA metabolisms has emerged to play crucial roles in disease
etiology. Pathological inclusions and/or genetic mutations in several RNA-binding proteins are
widely found in the two diseases. Alternatively, the hexanucleotide repeat expansion in the non-
coding region of C9ORF72 gene could also induce toxicity from the repeat RNA-derived products.
This supports the susceptibility of neurons to the dysfunction of RNA processing and the
importance of RNA homeostasis in preserving neuronal integrity. RNA modifications have recently
emerged to play important roles in posttranscriptional gene regulation. N6-methyladenosine (m6A)
is by far the most abundant internal RNA modification of eukaryotic cells. m6A modification is
dynamic and reversible, providing an additional layer of regulation on RNA. It is noted that m6A is
most enriched and the methylome is highly specific in the nervous system compared to other
tissues. Emerging studies indicate the important roles of m6A in regulating brain function, from
development to synaptic plasticity, learning and memory, and neurodegeneration. But it has not
been explored in ALS/FTD or other neurodegenerative diseases.
The hexanucleotide GGGGCC repeat expansion located in the first intron of the C9ORF72
gene is the most common cause of both ALS and FTD. The leading hypothesis for the disease
mechanism is gain of toxicity from the expanded repeats, with two non-mutually exclusive
mechanisms: 1) RNA foci formed by repeats that could sequester RNA binding proteins and
disrupt RNA processing; and 2) accumulation of dipeptide repeat proteins (DPRs) produced by
repeat-associated non-AUG translation (RAN translation). Our lab recently identified that m6A
RNA methylation can affect the DPR levels produced from the repeats. Furthermore, we also
found that the m6A pathway is profoundly reduced in C9ORF72-ALS/FTD patient neurons.
Therefore, it is important to determine the molecular mechanisms on how the m6A dysregulation
changes the repeat RNA metabolisms and disturbs the global mRNA processing, and how this
contributes to the neuronal dysfunction and degeneration in C9ORF72-ALS/FTD. Furthermore,
we will also determine whether targeting specific components in the m6A pathway can rescue the
disease-related phenotypes. This study addresses an emerging theme of RNA regulation that has
not been explored in neurodegeneration. The findings will help understanding the etiology of the
disease and developing novel therapeutic strategies for ALS and FTD.

Public health relevance
PROJECT NARRATIVE Repeat expansion in C9ORF72 gene is the most common cause of both amyotrophic lateral sclerosis (ALS) and Frontotemporal dementia (FTD), two adult onset neurodegeneration diseases. Dysfunction of RNA metabolisms has emerged to play crucial roles in disease etiology. Based on recent findings, we propose to decipher how the dysregulation of RNA modification affect the toxic repeat products and disturb the global gene network, and determine whether targeting the dysfunctional epitranscriptomic pathway can rescue the disease- related phenotypes.